Advancing Infrastructure, Collaboration, and Innovation across the Open-Source UCLA Miniscope Ecosystem

Project Summary
The Open-Source UCLA Miniscope Project has become one of the most widely used open-source tools in
neuroscience, democratizing access to innovative neural and behavioral imaging technologies. Over the past
eight years of active dissemination, more than 800 research groups across at least 18 countries have adopted
our tools, enabling groundbreaking research that was previously inaccessible due to technical and financial
barriers. Our commitment to open science has not only accelerated discoveries but also enabled a global
community of researchers collaborating across diverse disciplines.
Building on this success, our proposal seeks to further strengthen and expand the Miniscope ecosystem by
enhancing training, documentation, and support. We aim to create a more comprehensive and sustainable
framework that improves accessibility, fosters inclusivity, streamlines testing, integrates documentation within
development, and addresses key barriers identified during our extensive open-source dissemination efforts.
This includes delivering targeted, interactive training and support to empower researchers of varying
experience levels to adopt and adapt Miniscope tools confidently. Additionally, we will significantly expand our
day-to-day support mechanisms to better serve the large and growing community of users.
A key focus of this proposal is to continue expanding our reach to underrepresented groups and resource-
limited regions. By implementing targeted dissemination strategies and building partnerships with external
organizations, we will conduct annual workshops in low-resource countries and use the Miniscope platform to
promote STEM education and research in underserved communities. Through these efforts, we aim to reduce
barriers to scientific engagement and enable researchers in areas where resources are limited.
To ensure the long-term sustainability of the Miniscope ecosystem, we will establish a flexible framework for
integrating new features and technologies developed by both our team and the broader research community.
By creating a structured and systematic approach to incorporating advancements, we will maintain the
Miniscope platform's cutting-edge relevance and ensure that users can seamlessly benefit from the latest
innovations without disruption.
Through this initiative, we aim to 1) rebuild foundational practices to enhance dissemination and community
engagement, 2) establish a sustainable framework for integrating, disseminating, and supporting new features
and technologies, and 3) expand tailored support and training programs for a diverse range of users. Through
these efforts, we will provide researchers globally with the support, training, and resources they need to
advance neuroscience, fostering new discoveries and accelerating progress in the field.

Public health relevance
Project Narrative This project will enhance the UCLA Miniscope ecosystem, an open-source project that develops and supports novel neural and behavioral imaging tools used by hundreds of researchers worldwide, by expanding training programs, improving documentation, increasing community engagement, and strengthening user support. By disseminating these tools more effectively and empowering a broader range of researchers to utilize them, the project will accelerate neuroscience research and democratize access to advanced imaging technologies. These efforts have the potential to deepen our understanding of brain function while broadening access to scientific discovery.